VITAMIN A SUPPLEMENTATION FOR HIV-INFECTED CHILDREN

The purpose of the study is to determine whether vitamin A supplementation can enhance immunity and reduce morbidity and mortality for HIV-1 infected children. We propose to conduct a randomized, placebo- controlled clinical trial of vitamin A supplementation for HIV-infected children in Rwanda, Africa. Our preliminary studies show that vitamin A deficiency is relatively common in HIV-infected children and adults, that vitamin A deficiency is associated with increased mortality during HIV-I infection, and that high vitamin A intake is associated with slower progression to AIDS. Vitamin A is an essential micronutrient for mucosal, humoral, and cellular immunity, and vitamin A deficiency leads to increased susceptibility to infection. Vitamin A is known to restore mucosal integrity, enhance specific IgG responses, increase circulating CD4 T-cells, reduce anemia, and increase overall resistance to infection. In the last eight years, clinical trials have shown that vitamin A supplementation reduces revere infectious disease morbidity and mortality in children. HIV/AIDS is emerging as a leading cause of childhood mortality, and in developing countries there is no appropriate strategy to increase survival in HIV-1 infected children. The goal will be met through a clinical trial which utilizes infrastructure established during NIH-sponsored HIV/AIDS research in Butare, Rwanda. The specific aims are to determine if vitamin A supplementation will reduce morbidity and mortality, enhance immunity, increase hematopoiesis, and reduce HIV p24 antigenemia in HIV-1 infected children. If vitamin A supplementation is shown to reduce morbidity and mortality for HIV-infected children, this may be an appropriate, low-cost (8 cents per year, compared to $3000 for zidovudine) strategy to increase survival for HIV-infected children. Vitamin A supplementation has been shown to be one of the most cost- effective interventions to reduce mortality in children, and it remains to be determined whether it will be of health benefit to the growing numbers of HIV-infected children in developing countries.